ART Provider and Patient Resource to Improve Communication about Outcomes and Treatment (APRICOT)

Project Summary/Abstract Infertility affects an estimated 8-12% of reproductive-aged couples, leading many to seek assisted reproductive technologies (ART) treatments such as in vitro fertilization (IVF), gamete intrafallopian transfer (GIFT), and zygote intrafallopian transfer (ZIFT). Approximately 1.9% of infants born in the United States each year are conceived using ART. The Fertility Clinic Success Rate and Certification Act (FCSRCA) of 1992 mandates that clinics performing ART treatment annually report success rate data to the Centers for Disease Control and Prevention (CDC); however, clinics face challenges in collecting accurate pregnancy outcome information from these patients or the patients' new healthcare providers. To collect pregnancy outcomes, ART clinics rely on traditional outreach methods, including telephone, mail, and email, to obtain information from patients, who may be out of state or even country, and their obstetric providers. This process requires significant effort, often requiring multiple attempts. However, collecting this information is important because the CDC uses ART surveillance data to monitor the success rates of treatments performed in the U.S. and to characterize the short- and long-term health effects of ART on patients and infants conceived after ART treatments. To improve the response rates and data quality while reducing per patient costs, Charles River Analytics and our collaborator, Dr. Shruthi Mahalingaiah from Massachusetts General Hospital, propose to design and evaluate an ART Provider and Patient Resource to Improve Communication about Outcomes and Treatment (APRICOT). APRICOT is a health information technology (HIT) application to alleviate the burden on assisted reproductive technology (ART) clinics associated with collecting pregnancy outcomes from prior ART patients and the patients' other healthcare providers. Under this Phase I effort, we will use human factors engineering methods, including qualitative research methods, contextual design, and user acceptance testing, to elicit clinic and patient user requirements, design candidate workflows and user interfaces, and demonstrate the feasibility of developing APRICOT. Our effort will establish ART clinic and patient user requirements and produce conceptual designs for a pregnancy outcome reporting platform that facilitates streamlined communication between ART clinics and their patients. APRICOT will enable fertility clinics to collect pregnancy outcome information efficiently and effectively from prior ART patients and the patients' other healthcare providers. APRICOT will assist clinics in meeting federally mandated reporting requirements by reducing the effort required of clinic staff to collect pregnancy outcome information from previous ART patients and their obstetric providers, helping clinics to realize time and monetary cost savings in collecting pregnancy outcomes from prior patients.

Public health relevance
Project Narrative The Fertility Clinic Success Rate and Certification Act (FCSRCA) of 1992 requires fertility clinics that perform ART procedures (i.e., handling eggs and embryos) in the United States to report pregnancy outcomes to surveillance organizations, such as the Centers for Disease Control and Prevention (CDC). Our research effort will use empirically based human factors engineering and behavior science methods to design and evaluate an ART Provider and Patient Resource to Improve Communication about Outcomes and Treatment (APRICOT). APRICOT will enable fertility clinics to collect pregnancy outcome information efficiently and effectively from prior ART patients and their other healthcare providers.